Deciphering SPTAN1-associated disease mechanisms and potential therapy in patient-derived cell lines

Project Summary
Developmental and epileptic encephalopathy 5 (DEE5) is a rare neurodevelopmental disorder caused by
monoallelic pathogenic variants (PV) in SPTAN1, which encodes non-erythrocytic αII-spectrin. Individuals with
c.6908_6916dup (p.D2303_L2305dup) and the c.6619_6621del (p.E2207del) PV experience infantile epilepsy
with refractory seizures, profound developmental delay, hypotonia, and microcephaly. There is no available cure
for the affected children, and the current treatment goal aims to improve quality of life. However, there remains
a significant need for therapy development as multiple reports of failure to respond to anti-seizure medication
have been documented. Typically, children harboring the duplication variant succumb to the disorder before 6
years of age. Previous studies in patient-derived fibroblasts and transfected mouse neurons had demonstrated
a dominant-negative consequence of the variants resulting in aggregation of αII with β spectrins and a disrupted
axon initiation segment based on Ankyrin G and voltage-gated sodium channel signals. However, there is a lack
of connection between the molecular phenotypes and the clinical seizure phenotypes. Hence, there is a critical
need to clarify the fundamental molecular factors involved and assess the cellular and biochemical properties
using patient-derived cells and a mouse model to develop feasible therapy for the affected individuals. The
overall goal of the proposed work is to better the understanding of the molecular consequences of DEE5 (Aim
1) and develop appropriate assays and a generalizable pipeline for screening antisense oligonucleotide (ASO)
therapy that addresses the dominant-negative neurodevelopmental disorders (Aim 2). The applicant
hypothesizes that the SPTAN1 PV variants aggregate with SPTBN4 at the axon initiation segment to cause
aberrant action potential and thus seizures, and the wildtype protein function can be restored by knocking down
the variant allele using ASO. The applicant will use lineage-appropriate patient-derived cell lines as well as
develop a humanized mouse model to fully assess the disease mechanisms underlying DEE5 and will design
and screen RNase-H-dependent ASOs in patient-derived cell lines to determine the effective therapeutic
approach for alleviating cellular phenotypes. The proposed work serves instrumental value to the scientific
community and patient families by providing an extensive understanding of SPTAN1 dominant-negative disease
mechanisms, a valuable mouse model for future research, and supportive preclinical evidence for treatment
development. This project is designed to prepare the applicant for a career as an independent scientist in
translational research and furthers the applicant’s long-term goals of contributing to the preclinical development
of rare genetic disorders affecting the central nervous system.

Public health relevance
Project Narrative The project serves to determine how the c.6908_6916dup (p.D2303_L2305dup) and the c.6619_6621del (p.E2207del) mutations in SPTAN1, a subunit that is a part of the large spectrin protein helping to stabilize and organize neuronal membranes, cause severe developmental epileptic encephalopathy type 5 (DEE5). Specifically, this project will investigate the molecular interactors of SPTAN1 and determine the specific and effective therapeutic targets within individuals to alleviate the phenotypes associated with the mutations. The goal of this project is to reduce the burden of disease in individuals affected by the mutations described above by providing preclinical evidence of disease mechanisms and therapeutic strategies for potential clinical development.